Genetic and Proteomic Approaches to Reveal Bacterial Vulnerabilities to Phage Predation

PROJECT SUMMARY
We are entering a post antibiotic world where understanding the mechanism of an antibacterial strategy is not
sufficient to ensure an effective therapy. We must also consider the mechanisms of resistance and address them
during the design process. We will use genetics and proteomics to discover how bacteria combat bacteriophage
(phage) lysis. Driving this goal is the desire to combat phage resistance mechanisms so as to make bacteria
more susceptible to phage predation. We first tackle the problem by employing state of the art genetic methods
to interrogate the role of essential genes in limiting phage replication and bacterial lysis. Using CRISPR
transcriptional interference (CRISPRi), we will conduct the first studies in the human pathogen Pseudomonas
aeruginosa to determine whether partial knockdown of essential genes can positively impact phage replication.
We hypothesize that inhibition of certain essential genes will not only limit bacterial fitness, but also has the
potential to enhance the success of any phage-host pairing, regardless of whether the a priori state is one of
phage resistance or sensitivity. Put another way, even phages that already replicate in a given host can do better.
We will additionally harness the ease of CRISPRi screening to identify non-essential genes that limit phage
replication in strain-dependent manners, more akin to canonical hypervariable immune systems (e.g. CRISPR).
To further our understanding of the physical underpinnings of phage resistance, we will create a physical map
of phage-host protein-protein interactions using whole cell fractionation proteomics. This is particularly critical as
many phage proteins are of unknown function and is in line with our goal of identifying essential protein
complexes interacting with phage factors. We will validate the importance of factors identified from genetic and
proteomic assays with phage replication assays during single gene knockdown to assess generalities of
phenomena observed. Lastly, we suspect that phage “accessory genes” (i.e. hypervariable loci not strictly
essential for phage replication in all hosts) represent a treasure trove of inhibitors and modulators of host
processes, which could be useful genetic fodder for enhancing future phage therapeutics. Accessory genes have
been bioinformatically identified and host binding partners will be identified with conventional affinity purification-
mass spectrometry, and validated with phage replication assays. Our research strategy combines the
complementary expertise of three investigators: Joseph Bondy-Denomy, an expert in phage biology and bacterial
immune systems; and Danielle Swaney, an expert in bioanalytical mass spectrometry who has used her skills to
define the host-pathogen protein-protein network for many human pathogens; and Jason Peters, a microbiologist
with expertise in bacterial genetics and pathogenesis.

Public health relevance
PROJECT NARRATIVE Just like human cells, bacteria are susceptible to fatal viral infections. Recently there has been increasing excitement about the possibility of using bacterial viruses (called bacteriophages) for therapies to treat bacterial infections as bacteriophages are harmless to human cells. In this proposal, three researchers with complementary expertise join to uncover novel mechanisms by which bacteria fight off bacteriophage infections, with the goal of “helping” the bacteriophages to kill the bacteria more effectively.